HT protein profiling with a Next-Gen Protein Assay (NGPA)

ABSTRACT The goal of this proposal is to develop a highly-scalable technology for proteome analysis. The approach is broadly applicable and should greatly improve upon cost, sensitivity, usability, and throughput of proteomics and help democratize proteomics for R&D research.

Public health relevance
NARRATIVE This proposal aims to develop technology for user-friendly, high-throughput analysis of proteins using both sample and analyte multiplexed assays. By making information about proteins more readily accessible, this technology has the potential to advance basic research in almost every area in molecular life sciences, as well as applied and clinical research, including drug target discovery and drug development.